Roundtable on the Promotion of Health Equity and the Elimination of Health Disparities - Strategies for Ensuring the Inclusion of Minority Groups in Clinical Trials: A Workshop

Project Summary Over the course of the next twelve months, the planning committee will hold biweekly conference calls. The workshop itself will allocate time for public comments to be received. The workshop will be a one-day public meeting that will focus on identifying the causes for the underrepresentation of racial and ethnic minorities in clinical trials, describing the barriers to increasing participation in clinical trials for members of racial and ethnic minorities, and discuss ways to address these barriers. The workshop will also identify potential strategies and practices to improve the recruitment and retention of racial and ethnic minorities into clinical trials.

Public health relevance
Public Health Relevance Statement An ad hoc committee of the Institute of Medicine (IOM) will conduct a one day public workshop to focus on the underrepresentation of racial and ethnic minorities in clinical trials. Specifically, the planning committee will have biweekly conference calls to plan the workshop. The workshop, which will be open to the public, will (a) identify the causes for the underrepresentation of racial and ethnic minorities in clinical trials, (b) describe the barriers to greater participation for members of racial and ethnic minority groups in clinical trials, (c) discuss ways to address these barriers, and (d) identify potential strategies and practices to improve the recruitment and retention of racial and ethnic minority group members into clinical trials.